Disruption of lateralized auditory cortical function in a mouse model of Rett Syndrome

Project Summary/Abstract
Communication deficits are the most common disabilities in children, affecting 11% of
preschoolers. Although the causes of communication deficits vary, the underlying
pathological mechanisms are believed to converge at the level of neural circuitry
dysfunction. The focus of this project is to identify deficits in neural function specializations
for vocalization processing in a mouse model of Rett Syndrome (MeCP2 loss), a form of
autism spectrum disorder (ASD). A core deficiency in ASD is language impairment, which
is accompanied by atypical brain lateralization of language processing. This change in a
fundamental feature of speech perception disrupts the division of labor between the left
and right auditory cortices that is crucial to rapidly parse and decode fleeting vocalizations.
The mouse is a relevant species in which to study communication disorders based on the
similarities between the murine and human vocalization processing systems. The long-term goal of this laboratory is to develop an efficient pipeline to link ASD risk genes with
functional communication deficits, targeting molecular pathways and critical
developmental time points for therapeutic intervention. The objective of this proposal is to
determine how MeCP2 loss translates into deficits in hemispheric specializations for
vocalization processing that are shared between humans and mice. Aim 1 will identify
deficits in lateralized function (in vivo), aim 2 will identify abnormalities in the local
connectivity of excitatory and inhibitory neuron populations (in vitro), and Aim 3 will
examine interhemispheric communication dysfunction. Disruptions in the timing of critical
periods are a well-established consequence of MeCP2 loss. Therefore, we predict that
this deficit prevents the normal development of lateralized auditory specializations, leading
to a loss of the neurotypical hemispheric division of labor that is critical for processing
social communication. This approach is innovative because we are the first group to
identify lateralized circuit and functional features in auditory cortex, and we can leverage
this knowledge to identify abnormalities in hemispheric specializations of vocalization
processing. The proposed research is significant because it is expected to reveal
fundamental insights into how hemispheric specializations relevant to vocal
communication go awry in a mouse model of ASD.

Public health relevance
Project Narrative Atypical lateralization of auditory processing is a biomarker associated with language impairment deficits in autism spectrum disorder (ASD). The proposed project is relevant to public health because it will investigate the impact of MeCP2 loss, a mouse model of a neurodegenerative form of ASD called Rett syndrome, on the neural circuits underlying lateralized vocalization processing functions that are shared between humans and mice. The long-term goal of this proposal is to establish a pipeline to study and rescue functional communication deficits in mouse models of ASD, which will in turn identify molecular pathways and critical development time periods as targets for the development of human therapeutic interventions.